Chaperone protection in Lewy body and Alzheimer’s dementias: determining the structural, molecular and cellular mechanisms of a novel, non-canonical Hsp70 action blocking a-synuclein oligomerization

PROJECT SUMMARY/ABSTRACT
In the US, Lewy body dementias (LBD) and Alzheimer’s disease (AD) affect over 7 million people. No treatment
slows their inexorable decline. Broad evidence implicates malicious roles of α-synuclein (ASyn), tau and Abeta
(A) proteins in these dementias. LBD and AD are characterized by the sequential misfolding of ASyn, tau and
A into toxic oligomers and fibrils that propagate in prion-like fashion and accumulate in pathological deposits,
with ASyn the predominating pathology in LBD and A and tau pathologies predominating in AD. ASyn or A
precursor gene alterations cause LBD and AD respectively. Although central to disease, ASyn, A and tau mis-
folding have been challenging to target therapeutically. ASyn, tau and A pathologies correlate with LBD and
AD decline. Elevated levels of the stress-induced chaperone Hsp70 protects against ASyn misfolding and neu-
rodegeneration in LBD cell and animal models. However, there is minimal mechanistic understanding of this
important protective pathway. In particular, it is generally assumed that the canonical and promiscuous mode of
Hsp70 action underlies Hsp70-ASyn protection. Consequently, translational investigations have been stymied
by the anticipation of undesirable side effects of therapeutically targeting Hsp70 canonical actions. Our data
contradict this assumption, providing a potentially more targeted and exploitable mechanism of Hsp70-mediated
protection in disease. We find that Hsp70 blocks the earliest and most neurotoxic stage of ASyn misfolding,
ASyn oligomerization, by interacting at a previously unknown site separate from its canonical site of action. It is
therefore plausible that targeting this non-canonical mechanism would protect against disease. Importantly, this
approach holds the potential to correct ASyn misfolding without disrupting critical cellular processes. Our central
hypothesis is that this novel, non-canonical blockage of ASyn oligomerization by Hsp70 is protective in LBD and
AD. The next steps to support and exploit this hypothesis are to determine the molecular mechanism of Hsp70’s
engagement with ASyn, to validate this mechanism as protective, and test its action on additional AD/LBD pro-
teins. In Aim 1, we will determine the critical molecular residues in Hsp70 for blockage of ASyn oligomerization
and toxicity. We will use state-of-the-art cryo-EM microscopic approaches to capture how ASyn binds to Hsp70
with atomic resolution and validate the role of this binding through mutational analysis in LBD-relevant biochem-
ical and cellular ASyn oligomerization and toxicity assays. This will directly test our hypothesis that non-canonical
Hsp70 engagement of ASyn underlies its activity in blocking ASyn oligomers and in providing protection against
ASyn toxicity in neurons. In Aim 2, we will determine the impact of Hsp70 non-canonical action on oligomeriza-
tion of additional AD and LBD-relevant protein species, including lipid-bound ASyn and tau and A proteins.
Confirming an effect of non-canonical Hsp70 action on multiple pathogenic proteins would greatly expand the
therapeutic potential of this effect, and suggest that non-canonical Hsp70 plays a broader and so far unsuspected
role in many additional biological processes.

Public health relevance
PROJECT NARRATIVE In Lewy body dementia (LBD) and Alzheimer’s disease (AD) models, Hsp70, which assists in protein folding, can correct pathology caused by -synuclein, tau and Abeta proteins. While the mechanism of Hsp70 protection is unknown, our data suggest a very non-standard and specific mode of action, which we seek to determine in atomic detail and verify both in LBD cell models and in AD (tau and Abeta) biochemical assays. If verified, this mechanistic understanding will provide a specific pathway to exploit for treatment of LBD and AD.